Developing evidence-based objective tools for managing children with auditory neuropathy spectrum disorder

PROJECT SUMMARY/ABSTRACT
Auditory Neuropathy Spectrum Disorder (ANSD) is a clinical diagnosis that is characterized by abnormal
cochlear nerve (CN) function as indicated by absent or abnormal auditory brainstem responses in conjunction
with some normal hair cell function as evidenced by the presence of cochlear microphonics and/or otoacoustic
emissions. Current intervention options for ANSD include the use of hearing aids (HAs) and cochlear implants
(CIs). Auditory abilities among patients with ANSD are extremely diverse and cannot be predicted based on the
severity of hearing loss. Overall, ANSD remains a mystery despite decades of research. The current clinical
paradigm for managing ANSD solely depends on reliable behavioral responses from patients, which is
impossible in infants and many children with ANSD due to their young age and/or comorbidities. As a result,
even though early identification of ANSD through effective newborn hearing screening programs is possible,
implementing appropriate interventions for individual patients is delayed, which can have lasting detrimental
effects on communication skills development. The proposed study aims to translate scientific findings in objective
measures into clinical tools to address the following unmet, urgent clinical needs for managing patients with
ASND: 1) how to determine whether the CN responds to acoustic stimulation in clinical settings, 2) how to
determine the degree of hearing loss, 3) how to determine appropriate CI programming settings, and 4) how to
accurately assess whether individual patients are making appropriate progress with HAs or CIs in a timely
manner. In Aim 1, we propose to establish the electrocochleography recorded at the tympanic membrane as a
noninvasive, clinical tool to evaluate frequency-specific CN function in patients, including children with ANSD. In
Aim 2, we propose to establish the onset cortical auditory evoked potential (CAEP) as a clinical tool to objectively
assess ear- and frequency-specific, audiometric thresholds in children with ANSD and children with conventional
sensorineural hearing loss, as well as to validate the degree of cortical neural synchrony as an early identifier of
the patients with ANSD who need to transition from HAs to CIs. In Aim 3, we propose to establish the clinical
applications of the electrically evoked onset CAEP and the stapedial reflex threshold to assist in the CI
programming process and to establish the degree of peripheral neural synchrony as a robust indicator to predict
CI benefit for individual children with ANSD. This study has tremendous clinical significance because 1) it will
shift the clinical paradigm for ANSD management from solely relying on behavioral response to a synergistic
approach that includes both objective and behavioral measures, and 2) it will improve clinical care of children
with SNHL who cannot provide reliable behavioral responses.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to public health because it aims to translate scientific findings into clinical tools to improve clinical diagnosis, assist in intervention strategy implementation and accurately predict intervention outcomes for individual patients with auditory neuropathy spectrum disorder (ANSD). This project is relevant to the mission of NIH because it applies fundamental knowledge about auditory electrophysiology and auditory perception to improve clinical care and therefore reduce disability in patients with ANSD.